PARAMAGNETIC PROBES FOR TERTIARY STRUCTURE DETERMINATION

The development of a new method for tertiary structure determination of proteins is proposed. The approach may be applied to both membrane and globular proteins. As such, it represents a potentially powerful and novel method for new structure determination via a combination of NMR and computational methods. The approach uses cysteine scanning mutagenesis with site-directed paramagnetic probes to introduce paramagnetic centers in diamagnetic molecules. The resulting pseudocontact shifts are expressed as a function of the local tensor at the probe site and the distance and angle between the site and each nuclear spin. The nature of this new information: a) long-range, b) applied to multiple sites, and c) used in conjunction with other NMR information (e.g. NOEs, scalar coupling constants) provides restraints to be used in structure refinement. The approach will be tested in two systems with known tertiary structures. Computational methods will center on both ab initio calculations for the local g-tensor as well as the use of the CHARMm molecular dynamics program for refinement with pseudocontact shift restraints. The specific aims are: I A. Ab initio quantum chemical calculations of the g-tensor: The g- tensor, calculated via ab initio methods, will be used to determine the pseudocontact surface for structure refinement. A description of the change in tensor with molecular motion will be parameterized. I B. Molecular mechanics structure refinement. The restraints from pseudocontact induced shifts will be applied as energy penalties within the CHARMm code. Refinement will use simulated annealing. The accuracy of the approach will be tested with calculated dynamical trajectories. II A. Use of the g-tensor calculations for the zinc-finger binding protein. The cobalt substituted zinc-finger binding protein, with known tertiary structure, provides an initial test of the approach. II B. Site directed paramagnetic probes within T4-Lysozyme. Two probe types, optimized for shift effects and minimal relaxation effects, will be used. The T4-Lysozyme system will provide an excellent test of the approach for a globular protein with many mutants and known tertiary structures. The determination of new tertiary structures are important for rational drug design.